Immune Monitoring and Biospecimen Core

PROJECT SUMMARY/ABSTRACT
The Immune Monitoring and Biospecimen (IMB) Core is a dedicated to provide the outstanding leadership and
expertise in immune monitoring and biospecimen sciences needed in this U19 to develop novel effective agents
that can cross the blood brain barrier (BBB) and test them in the clinic. Working collaboratively as a team the
investigators at University of California San Francisco and Northwestern University will acquire, process, and
analyze biospecimens from enrolled patients and from preclinical models for GBM. Many of the procedures
required to achieve these objectives are non-standard, requiring specialized knowledge and sophisticated
experimental analysis. In addition, the Core will provide histopathologic and molecular analyses of human glioma
xenografts, central histopathologic review, and ensure strict quality control in all aspects of biospecimen
handling. The Core will address these needs based on the following specific aims:
Specific Aims
1. To provide the staff and expertise for the acquisition and preservation of high-quality brain tumor patient
biospecimens and preclinical models to meet the tissue accrual requirements for the projects and clinical
trials.
2. To provide routine and advanced tissue handling/processing and analytical techniques and expertise for
human and murine tumors, including high-dimensional flow cytometry, multiplex immunoflourescence,
Cytek, and single cell RNA sequencing, that will advance project hypothesis development and goal
attainment.
3. To provide the neuropathologic expertise for interpretation of the tumor tissue and extraction of appropriate
quantitative and semi-quantitative parameters.
4. To provide consistent oversight of the Core activities that will ensure the stringent compliance with regulations
governing informed consent and patient confidentiality, as well as management of the biospecimens and the
information derived from the biospecimens.